AIDS CLINICAL TREATMENT UNIT--PROTOCOL 03

AIDS is a human disease first recognized in the U.S. in 1981, characterized by profound alterations in immune function affecting primarily T-cell function. A study to evaluate the safety and efficacy of AZT in patients with early AIDS-related Complex.